Core 3: Patient Data

Project Summary
Overall, the primary effort of this Core will be to conduct a master imaging trial for patients undergoing RPT
treatment at Johns Hopkins, as well as to establish deep research collaborations among investigators,
collaborators and industry sponsors. For Aim 1, the Core Investigators will conduct a master imaging trial
(SeeToTreat) to acquire data for the P01 projects, with flexibility to include patients receiving standard of care or
research RPT on other protocols. For Aim 2, Dr. Sgouros, Dr. Kiess and the research staff have established
deep research collaborations with Bayer (227Th-HER2-TTC and 227Th-PSMA-TTC), Rayzebio (225Ac-
DOTATATE), and Cornell (225Ac-J591) to support the P01 Projects as well as future collaborative work. These
research collaborations will include sharing of images and data from completed and ongoing clinical studies,
including SPECT dosimetry, PET surrogate images and response data. The industry research agreements are
now fully executed. For Aims 3 and 4, the Core will establish a de-identified RPT database of images, absorbed
dose, tumor response and toxicity data. This will include collection of data from SEEtoTREAT, RAVENS, and
from industry and academic collaborators.

Public health relevance
Project Narrative The Patient Data Core will provide oversight of patient data collection and use required to complete the scientific objectives of the program project, assuring that Investigators have access to the required data with adherence to all standards of privacy and ethics. This core will also work towards increasing collaboration and data sharing among academic and industry researchers in the field of radiopharmaceuticals, as well as encouraging data collection as part of standard of care radiopharmaceutical therapy, to strengthen future scientific inquiry in this exciting and growing field.